Candida albicans secreted protease Sap6 engages epithelial protease-activated receptors PAR2 and NLRP3

Candida albicans pathogenicity is associated with its morphological transformation from yeast to
production of filamentous hyphae. Secretion of hyphal-specific proteins, particularly the aspartyl
protease Sap6, is a key marker of its transition from commensalism to virulence. Sap6 contains
both a proteinase domain and an RGDRGD integrin-binding motif adjacent to its catalytic domain.
We found that rSap6 added to primary oral epithelial cells (OECs) elicited IL1β secretion typical of
NLRP3 signaling but also produced IL-8. Sap6 added to OECs induced phosphorylation of p38 and
IL-8 production through the protease- activated receptor (PAR2). PAR2 signaling was lost upon heat
inactivation of Sap6, while NLRP signaling was reduced upon deletion of Sap6 RGD-binding sites,
leading to our hypothesis that both Sap6 proteolytic and RGD-mediated mechanisms are involved in
sensing levels of this fungal secreted protein by OECs. We will test this hypothesis by identifying the
proteolytic mechanism for Sap6 activated PAR2 MAPKinase signaling in OECs in Aim1, and
assessing the contribution of the Sap6 integrin-binding RGD motif in NLRP3 inflammasome
activation and apoptosis in Aim 2. This work will establish PAR2 and integrin/NLRP3 as cell surface
receptors for C. albicans Sap6 and define their role in modulating host inflammatory responses to
fungal proteins in OECs. The long-range goal of this project will be to activate/deactivate PAR2
receptors or NLRP3 signaling as a means of modulating host inflammation as an avenue for
treatment of candidiasis.

Public health relevance
Candida albicans is an opportunistic fungal pathogen that releases proteins during filamentation, colonization and invasion of human oral epithelial cells. One such protein, the secreted aspartyl protease Sap6, is associated with virulence of this fungus by producing host inflammation, although how host cells recognize this protein is unknown. The goal of this project is to identify host surface receptors that recognize Sap6 to trigger inflammation in epithelial cells with the long-range goal of blocking these interactions as a treatment strategy for fungal infections.